A web-based patient-reported symptom monitoring and self-management portal for adolescent and young adult breast cancer survivors

Abstract
No changes to abstract from parent award. Please see Research Strategy.

Public health relevance
Project Narrative No changes to Project Narrative from the parent award.